A pulse-labeling assay to track extracellular vesicle spreading in the brain

PROJECT SUMMARY
Extracellular vesicles (EVs) are nano-sized secreted vesicles that carry biomolecules and mediate cell-cell
communication. EVs are implicated in the development and progression of Alzheimer’s disease (AD) through
their role in spreading pathogenic proteins (i.e. amyloid-beta, Tau) through the brain. EVs also have utility as AD
biomarkers, given their ability to cross the blood-brain-barrier (BBB) and their presence in multiple bodily fluids.
Further, EVs are promising drug delivery vehicles, with the ability to target specific cell types. However, despite
their promise as biomarkers and therapeutics, EV biology remains poorly understood due to the lack of tools for
visualizing EVs in their physiological environments. Such tools will be essential for uncovering mechanisms of
EV spreading and uptake by different brain cell types, information critical for slowing AD progression and
harnessing EVs as AD therapeutics. In the current proposal, we will develop a pulse-labeling assay for tracking
cell type-specific EV secretion and spreading in the murine brain (Aim 1). We will then use this assay to examine
how APOE4 genotype, the strongest genetic risk factor for AD, impacts EV spreading in the dentate gyrus (Aim
2). The Halotag EV pulse-chase (HEVPL) assay will have the following three components: 1) EV-enriched
tetraspanin membrane proteins conjugated to the self-labeling Halotag, to enable in vivo pulse labeling with
fluorescent ligands that cross the BBB and covalently attach to Halotag; 2) AAV delivery coupled with cell type-
specific promoters/enhancers to express tetraspanin-Halotag proteins in specific brain cells; 3) coexpression of
tetraspanin-Halotags with GFP at equimolar concentration via the 2A cleavage sequence, allowing us to
distinguish GFP+ ‘donor’ cells that secrete tetraspanin-Halotag-containing EVs and GFP- ‘recipient’ cells that
internalize these EVs. The assay will be developed through in vitro and in vivo experiments to optimize
tetraspanin-Halotag expression and labeling, test the assay’s dynamic range, and determine the time course
over which labeled EVs can be detected in the brain. In Aim 2, we will use HEVPL to visualize the impact of the
APOE4 gene on EV secretion and spreading from granule cells of the dentate gyrus (DG). ApoE4 was recently
shown to compromise global EV secretion in aging humans and mice, but the specific cell types and brain regions
impacted remain unknown. The DG is one of the earliest brain regions affected in AD, and granule cells appear
to be particularly vulnerable to ApoE4-related pathology. Using the AAV-mscRE4 enhancer to drive CD63-
Halotag expression in granule cells, together with Halotag pulse-labeling and automated confocal microscopy/3D
image reconstruction, we will quantify and compare EV secretion and spreading over time for humanized APOE3
vs. APOE4 mice. These experiments will provide the first information about how ApoE4 impacts EV release and
spreading in an AD-vulnerable brain region, shedding light on a mechanism by which APOE4 genotype may
accelerate AD progression.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease (AD) is the most common cause of dementia and a leading cause of death in the United States, with no effective treatments to slow or halt disease progression. This proposal will develop an assay to visualize the secretion and spreading of nano-sized extracellular vesicles (EVs) in the brain, a process with great relevance to AD pathophysiology, diagnosis, and treatment.